NHP Core

SUMMARY
Infection of rhesus macaques with simian immunodeficiency virus (SIV) or simian-human immunodeficiency virus
(SHIV) is a key animal model for HIV-1 infection. Nonhuman primates (NHP) are complex, higher order species
that require specialized infrastructure and experienced staff in a research setting. Core D (NHP Core) aims to
support this P01 program by providing all the expertise, infrastructure, reagents, personnel, animals,
and logistics for the conduct of complex in vivo studies in rhesus macaques. Core D will involve leadership
from Beth Israel Deaconess Medical Center and Bioqual and is well positioned to meet program objectives. The
goal of Core D is to provide leadership and technical expertise to ensure consistency and quality control in
animal selection, execution of study protocols, experimental procedures, sample acquisition and distribution, and
data collection and analysis. To accomplish this goal, we propose three Specific Aims:
Aim 1. To support this P01 program by selecting and providing rhesus macaques, providing exceptional animal
care, and conducting experimental vaccine studies
Aim 2. To provide facilities for the receipt, cataloging, processing, storage, and distribution of blood and tissue
samples in compliance with Good Clinical Laboratory Practice
Aim 3. To obtain and to maintain all required regulatory approvals for the proposed studies